A PRECLINICAL MODEL OF ALCOHOLIC HEPATITIS

Alcoholic Steatohepatitis (ASH) is a major cause of liver related mortality. Despite its public health significance,
there has been limited therapeutic advances for ASH. A principal barrier to acceleration of therapeutics is the
availability of a robust preclinical model of ASH which recapitulates human ASH. Such models are needed to
better understand the role of specific genes and pathways in human ASH e.g. the PNPLA3 mutation which is
associated with severe ASH and test promising compounds for both efficacy and safety. In this UH2/UH3
application, we propose to provide “proof of concept” that our recently validated diet-induced animal model of
NAFLD (DIAMOND) can be leveraged as a model of ASH with specific alcohol feeding protocols and will test
the following novel hypothesis: an inbred isogenic crossed C57Bl/6J and 129S1/SvlmJ (B6/S129) mouse strain
will develop steatohepatitis that recapitulates the key features of human ASH with alcohol feeding. Furthermore,
liver-specific expression of the human mutant I148M PNPLA3 in this mouse will accelerate the development of
ASH upon alcohol feeding. As per RFA AA-18-006, the studies will be performed in two phases: UH2 Phase
(yrs. 01-02): To demonstrate that alcohol feeding causes steatohepatitis resembling human ASH with respect
to histology, markers of liver injury and function, and activation of signaling pathways in an isogenic strain of
B6/S129 mice. Alcohol feeding will be done along with chow- or an obesogenic-diet. We will test the effect of
the NIAAA alcohol model feeding strategy (to be performed at NIAAA under supervision by Dr. Gao) and an
alternate strategy where we will perform single ascending dose (SAD) and multiple ascending dose (MAD)
studies that will provide optimized alcohol feeding strategies including amounts given chronically along with
binges to allow a phenotype of ASH to develop. We will also test the ability to accelerate development of ASH
by liver-specific expression of the human I148M PNPLA3 mutant gene. These data are based on preliminary data
indicating that NASH can be accelerated by this maneuver. A minimal requirement for development of ASH
(steatohepatitis, increased AST and bilirubin) will be needed to proceed to the UH3 phase. UH3 Phase (yrs.
03-05): To further validate the model, define the course of disease progression and regression by modulation of
alcohol intake, and the impact of ASH on the susceptibility to ASH in subsequent generations. The
transcriptome, metabolome and microbiome of the model will be related to human data from the AlcHepNet
consortium. Also, the effects of alcohol withdrawal after varying durations of exposure will be tested to define
the “off-response”. We will also perform studies to determine the susceptibility of offspring of mice that have
been allowed to develop ASH and then recover by withdrawing alcohol. Microbiome analyses will be done at
the UCSD site of AlcHepNet. The investigators have the required expertise in ASH and mouse models of NASH
and ASH. Together the studies will have a high impact by providing a mouse model of ASH. The project also
meets the high-risk high reward criteria for the UH2/UH3 funding mechanism.

Public health relevance
An isogenic B6/s129 mouse strain that consistently develops progressive NASH on a high fat diet will be provided alcohol feeding to determine if it develops ASH. The UH2 phase will determine is ASH can be induced and the UH3 phase will involve advanced validation of the model.